Generating an atlas of Richter's Syndrome: from molecular understanding to outcome prediction, detection and monitoring

Project Summary: Recent therapeutic advances have dramatically improved patient outcomes in chronic
lymphocytic leukemia (CLL). However, Richter's Syndrome (RS), which is the transformation of CLL to an
aggressive lymphoma (that occurs in 0.5-1% of CLL patients annually), is often refractory to existing therapeutic
approaches. Building on the success of our current P01 in creating the world's largest map of genetic drivers
and subtypes of CLL (n=~1100) and using it to build prognostic models, this renewal application seeks to apply
similar (and new) approaches to comprehensively map the genetic underpinnings of RS. Currently, and in
contrast to CLL, little is known about the genetics, clonal composition, drivers and cell circuitry of RS, and hence
there is neither a framework for molecularly based risk stratification nor targets for therapeutic development.
Therefore, understanding the molecular (genetic, epigenetic and proteomic) underpinnings of the transformation
from CLL to RS will create opportunities for more effective therapeutic interventions, prediction of response, and
potentially early detection, all with the goal of improving patient outcome. To achieve these goals, we propose
to: (1) Define the drivers of RS and delineate the relationship of RS to CLL and DLBCL. Using whole-exome and
RNA sequencing, we will study the genetic and transcriptomic landscape of >300 RS cases, including analyzing
their pre-transformation CLL and RS samples. We will then further delineate the genetic relationship between
CLL and RS using whole-genome sequencing of a subset of cases, and chart their epigenetic landscape using
chromatin and histone methylation profiling. Moreover, we will trace the evolution of the CLL cells to RS and
determine distinct patterns of genetic, epigenetic, and transcriptomic states at a single-cell resolution. Finally,
we will combine these data to identify molecular subtypes of RS and associate them with outcome. (2) Define
the changes in cellular circuitry associated with transformation from CLL to RS. We will use the power of
microscaled proteomic and phosphoproteomic analysis to identify changes in the wiring of cellular processes
associated with transformation to RS and create a comprehensive proteomic map of RS. We will identify
deregulated signaling pathways and potential therapeutic targets. Finally, we will integrate the proteomic data to
refine the molecular subtypes identified above as well as develop a high-throughput proteomic assay for
detecting biomarkers of these subtypes and validate them in an independent set of RS patients. (3) Develop a
non-invasive tool for RS detection and monitoring. Building on our understanding of the RS genome, we will build
a robust and inexpensive cell-free DNA assay based on low-pass whole-genome sequencing aimed at detecting
RS-specific alterations in plasma samples. We will test whether we can detect RS clones in patients' blood to
monitor the emergence, progression and relapse of RS. Together, these Aims will create the first comprehensive
atlas of RS, identify key pathways and potential therapeutic targets and build tools that could impact clinical
decision making.

Public health relevance
Narrative: Richter’s Syndrome (RS) occurs when a patient’s Chronic Lymphocytic Leukemia (CLL) transforms to an aggressive, and often deadly, lymphoma. Unfortunately, when this occurs, there are very few therapeutic options with limited success, which is in part due to our lack of understanding of the biology underlying this disease and what triggers the transformation from an indolent leukemia into an aggressive lymphoma. In this Project, we will create a comprehensive atlas of the molecular features of RS and discover the changes that drive this transformation, and use this atlas to develop tools for assessing a patient’s risk, as well as a blood- based test for identifying and monitoring the emergence or recurrence of RS.